Multi-omics study of ancestry enriched associations in Hispanics/Latinos

ABSTRACT
This proposal builds into our ongoing research in genetics and disease risk in admixed Hispanic populations.
Hispanics/Latinos are the larger racial/ethnic minority in the U.S. They have a high burden of cardiometabolic
and inflammatory related diseases. Genetically, Hispanics are an heterogenous population comprised of
multiple ancestral groups (primarily Native American, West African, European) from recent admixture. Few
studies have leveraged genetic ancestry to address differences in disease susceptibility. This study will
leverage the comprehensive data from the large population-based Hispanic Community Health Study/Study of
Latinos for discovery of ancestry-enriched susceptibility loci. We propose to integrate genomics and multi-
omics data to map genomic segments and variants inherited from the ancestral population with the higher
disease variant frequency (Aim 1), use new approaches for fine-mapping genomic regions (Aim 2), and
validate our findings for clinical relevance in Hispanics/Latinos from the All of Us study (Aim 3). We expect to
gain insights into the identified ancestry-related genomic regions and variants and their relationship to disease
states. This proposal uniquely complements large ongoing genome wide association approaches. Our results
may provide insights into differences in disease risk in admixed populations. Ultimately this research could
inform personalized medicine and improve public health.

Public health relevance
PROJECT NARRATIVE This project will use genomics and multi-omics to address important questions related to ancestry enriched genomic regions associated with clinical disease in Hispanics/Latinos, a minority population at risk of cardiometabolic diseases. Findings may have public health and clinical care implications.